De-Implementing Testing and Treating of Urine Cultures in Asymptomatic Patients

Background: Successful deployment of strategies to reduce unnecessary testing and treatment is a critical
component of improving care and minimizing harms. The Choosing Wisely Initiative has highlighted the
importance of safely and effectively de-implementing unnecessary testing and treating practices. Positive urine
cultures are a major driver of inappropriate antimicrobial use. Asymptomatic patients are often screened and
positive urine cultures treated, despite new guidelines from national societies that patients without symptoms of
urinary tract infection (UTI) should not have a urine culture performed and should not be treated with antibiotics
even if the culture is positive. This inappropriate use of antibiotics can lead to preventable patient harms (e.g.,
C. difficile infection, antibiotic resistance) without any benefit. This proposal will develop and test a de-
implementation strategy for reducing screening and treatment of urine cultures in asymptomatic surgical
patients.
Specific Aims: Aim 1: Develop a live database of the 15-facility CDC-CREATE Network to identify and to
track organizational, provider, and patient level factors associated with preoperative urine testing and ASB
treatment. Aim 2: Determine the current context of pre-operative urine testing and treating, and barriers and
facilitators to de-implementation, using in-depth interviews at 5 facilities in our CDC-CREATE network. Aim 3:
Develop a de-implementation tool and randomly select 5 intervention sites for pilot testing and compare rates
of urine testing in 5 randomly selected control sites using time series analysis.
Significance: This proposal meets the HSR&D Implementation Science priority area that addresses provider
behavior and Secretary Shulkin's Priority 3: Focus Resources More Efficiently. It also addresses the Infectious
Diseases Society of America #1 Choosing Wisely recommendation which says, “Don't treat asymptomatic
bacteriuria with antibiotics.” The impact on Veteran's healthcare will be to focus resources towards evidence
based practices that are associated with benefits (surgical prevention checklist) and away from potentially
harmful practices (urine testing and treatment in asymptomatic patients). This innovative approach will
translate new guidelines - to do less - into action using a theory based multi-pronged intervention.
Methods: We will partner with the De-implementation Quality Enhancement Research Initiative (QUERI) and
adapt their conceptual framework to achieve the proposal objectives. In addition, we will utilize our existing
partnership with the CDC-CREATE network of sites to evaluate the context, facilitators and barriers to stopping
urine culture practices in asymptomatic surgical patients and to pilot test a de-implementation strategy. We will
use a mixed-methods approach, including analyses of data from the national VA databases (e.g. Corporate
Data Warehouse), qualitative interviews, and piloting of a de-implementation strategy with a goal of wider
dissemination in future work. We anticipate that the de-implementation strategy created and tested in this study
will reduce urine testing and treatment in asymptomatic surgical patients.
Implications and Next Steps: Our study will provide important insights into patient, provider, and hospital
level factors, as well as organizational culture and broader external context (e.g., professional, social)
associated with unnecessary urine testing and antibiotic treatment of surgical patients. Our study will develop a
strategy to provide reliable, relevant data to the providers so they can do a critical assessment of the evidence
against urine testing (unlearning) and adopt a substitute process to optimize the success of our de-
implementation goal. Our next steps will be to test the intervention in a wider array of facilities and to work with
the Antimicrobial Stewardship Task Force to disseminate our findings to VA antimicrobial stewardship teams
nationwide. Our future goals are to disseminate the strategy nationally and to expand it to other patient
settings, such as acute care and community living centers.

Public health relevance
Inappropriate use of antibiotics is linked to antibiotic resistance and life-threatening adverse events. Positive urine tests are a major driver of inappropriate antibiotic use. Asymptomatic surgical patients are often screened before surgery and positive urine tests treated with antibiotics, despite guidance that patients without infection symptoms should not have a urine tests performed and should not receive antibiotics if the test is positive. The overall goal of the proposed study is to develop and pilot-test a de-implementation tool to end a common long- standing practice of screening and treating urine tests in asymptomatic surgical patients. First, we will use VA data to identify factors associated with urine testing and antibiotic treatment in surgical patients and track these in real time. Second, we will visit 5 VA hospitals and interview surgeons and other providers to determine why urine tests and treatment are done and what interventions would be acceptable. Third, we will create a tool to stop unnecessary urine testing and antibiotic treatment and evaluate it in 10 VA hospitals.